Quantitative Systems Pharmacology of Antibody Therapeutics across Diverse Biological Contexts

ABSTRACT
Antibody-based therapeutics have grown rapidly over the past two decades. However, many challenges limiting
the success of this drug class persist. First, the attrition rate remains high in antibody drug development. Second,
many antibody therapeutics exhibit only transient pharmacologic action. As a result, antibody therapeutics benefit
only a subset of patients. A key driver of these issues is our poor understanding of antibody pharmacology in
vivo across biological contexts. Our research has revealed that antibody pharmacology is highly dependent on
the physical and biological contexts of the biological environments where their actions occur. Methods and tools
that integrate tissue physiology, disease pathology, and immune status into the characterization of antibody
pharmacology are sorely needed. Leveraging multi-dimensional spatiotemporal data, we have developed
quantitative systems pharmacology (QSP) models and experimental tools that allow us to investigate many
facets of antibody context-dependent pharmacology, including tissue-specific pharmacokinetics (PK) and
pharmacodynamics (PD), disease pathology, antibody-mediated immune dynamics, and cell-cell interactions.
Our work has yielded insights for antibody drug development and therapeutic application. In this MIRA, we
propose to apply and refine these experimental and mathematical tools to continue our long-standing efforts to
address critical issues surrounding antibody context-specific pharmacology. Specifically, we will continue our
work in 1) measuring and modeling antibody tissue PK and target engagement in living animals; 2) modeling
antibody-mediated cell-cell contact and interactions across biological contexts; and 3) determining the roles of
the constant region (Fc) and effector function in soluble target neutralization. In project 1, our lab has developed
a proximity-based bioluminescence resonance energy transfer (BRET) imaging approach. This BRET imaging
technology can longitudinally measure antibody exposure and target engagement within tissues of living animals,
elucidating the physiological and biophysical factors that govern and restrict antibody−target binding processes
in vivo. In project 2, we will apply our proximity-based cell-cell imaging tools, coupled with a multidimensional
QSP model for cell-cell interactions, to uncover the biophysical principles of antibody-mediated cell-cell
communication. In project 3, we will investigate the multifactorial aspects of antibody pharmacology for soluble
target neutralization and highlight the critical but neglected roles of Fc variants and effector function. This project
could uncover overlooked mechanisms that have restricted antibody therapeutic development against soluble
targets and expand the field’s design space. Overall, our research will continue to address the fundamental
challenges to efficient antibody development and optimal therapeutic application through the development of
experimental tools and QSP models.

Public health relevance
PROJECT NARRATIVE Despite the rapid growth of antibody-based drugs, challenges limiting their success as a therapeutic class persist, including the development challenges of high attrition rates and the therapeutic challenge of heterogeneous benefit across patient populations. A key driver of these issues is our poor understanding of antibody pharmacology across biological contexts, and antibody therapeutics frequently fail in translation when their mechanism of action cannot keep up with the diverse and dynamic biological contexts and tissue environments. Our research has focused on developing systems modeling methods and spatiotemporally-resolved molecular imaging tools to investigate antibody pharmacology across biological contexts and resolve issues that hinder the development and application of antibody drugs.